Phenotype Predictors of Cognitive Outcomes in Geriatric Depression

In this competing renewal of R01MH108578, we are seeking to extend findings from the initial study to
focus on effects of stress in longitudinal mood and cognitive outcomes of late-life depression (LLD) and to
examine stress effects on brain structure and function in LLD. Severe or persistent stressors can result in a
number of behavioral and mood changes, including anxiety, dysphoric mood, sleep disruption, altered appetite,
and withdrawal from social and pleasurable activities. These stress-related consequences are particularly
salient when considering longitudinal outcomes of treated LLD. They may be compounded by an individual's
longstanding maladaptive patterns of response to stress, embodied in the construct of neuroticism, which we
have shown to be related to poor mood and cognitive LLD outcomes. Moreover, Andreescu et al. (2019)
introduced a model of depression recurrence that incorporates the homeostatic disequilibrium hypothesis,
which proposes that in geriatric remitted depression, neural networks are in fragile homeostasis that is
threatened by stress exposure. Networks of particular importance in stress of LLD outcome are the Default
Mode Network (DMN), Salience Network (SN) and Executive Control Network (ECN).
The Neurobiology of Late Life Depression (NBOLD) study began enrolling older depressed and never-
depressed controls in 2013, enrolling 132 depressed and 44 controls, and currently follows 77 depressed and
22 controls. Subjects are well characterized in terms of mood, cognition, personality and stress (including
specific measures obtained during the present COVID pandemic). It is well suited to examine stress effects on
longitudinal mood and cognitive outcomes. For the renewal, we will follow current subjects and recruit 75 new
subjects, who will be followed for up to 5 years with annual cognitive testing, stress measures and baseline
and two-year brain fMRI scan. In preliminary data presented in this application, we show that:
1) In depressed elders, compared with those who developed cognitive decline/dementia in 4 years, those who
remained cognitively normal had greater 2-year decrease in neuroticism and increase in Conscientiousness.
2) Worsening in stress over two years is associated with two-year decrease in hippocampal volume and is
associated with changes in functional connectivity of key brain regions..
3) In complex statistical modeling, interactions of changes in neuroticism and changes in the number of
stressors recently experienced are associated with cognitive outcome.
In this competing renewal, we will examine the following specific aims:
1. To study effects of stressors (obtained on a variety of measures) and neuroticism on longitudinal mood and
cognitive outcomes in older adults with history of major depressive disorder (MDD).
2. To study effects of stress and neuroticism on brain structure and function in older adults with MDD history.
3. To explore relationships among variables in Aims 1 and 2 with longitudinal multivariable statistical models.

Public health relevance
This study will focus on examining effects of stress on long-term mood and cognitive outcomes of late-life depression. It will also example the neural underpinnings of these changes using structural and functional brain imaging. Understanding how effects of stress in older depressed adults, as well as factors that might minimize those effects, lead to particular mood and cognitive outcomes will inform future development of novel prevention strategies.